Pilot Project Program

The Southwest Environmental Health Sciences Center (SWEHSC) Pilot Projects program facilitates the
implementation of the SWEHSC strategic vision and goal of testing the most innovative ideas relevant to
environmental health by fostering opportunities to fill important gaps in the SWEHSC research portfolio. To date,
the Pilot Project Program has enabled the successful creation of several scientifically productive collaborations
that have emphasized the strengths of the SWEHSC in the conduct of translational studies and aided in securing
significant extramural research funds for SWEHSC investigators. To support the SWEHSC strategic vision, the
Pilot Projects program provides short-term support for innovative projects that explore new areas of
environmental health research or that aim to acquire the preliminary data necessary to pursue long-term
extramural funding. As well, the Pilot Projects program supports the Career Development of new investigators
and highly successful senior investigators wishing to redirect their research to encompass environmental health.